Predicting ARDS trajectory with deep generative models of CT images

PROJECT SUMMARY
Acute respiratory distress syndrome (ARDS) is characterized by inflammatory lung injury, heterogeneous
pulmonary inflation, and hypoxemia. It requires mechanical ventilation to prevent immediate death. Tuning
ventilation settings to minimize harmful lung stretch, and ventilating patients in the prone position mitigate lung
injury and reduce mortality. However, responses to these interventions are not uniform and clinical progression
is poorly predictable. Clinical studies suggested that regional patterns of lung aeration (e.g., radiographic
consolidation vs. disseminated air loss) may be associated with distinct outcomes and different responses to
ventilatory strategies. Topological assessment via computed tomography (CT) could predict treatment
responses and facilitate personalized ARDS care, but this application of CT is hindered by subjective
interpretation and by the burden of image processing. Artificial intelligence (AI) algorithms, particularly deep
learning, are revolutionizing image recognition and processing tasks. Leveraging the latest AI developments in
image synthesis, the goal of this project is to develop, train, and test deep generative models using CT images
to objectively and rapidly predict lung injury progression and treatment responses.
We will develop generative adversarial networks (GANs) to synthesize: a) CT images that emulate responses to
interventions, and b) CT images that predict future injury morphology. The models will be trained using over
2000 paired CT images from different conditions, such as respiratory treatments and injury stages, previously
obtained from pigs with experimental ARDS. Moreover, we will create an image augmentation network with
GANs to address the potential scarcity of clinical datasets and possibly enhance prediction performance. Lastly,
we will evaluate the generative models in human ARDS cases. We will begin by retraining them to predict
treatment responses using existing clinical imaging datasets. Subsequently, we will predict injury progression
with prospectively collected longitudinal CT scans. We will also integrate clinical parameters, physiological
measurements, and inflammatory biomarkers to refine and enhance the generative models' ability to predict
ARDS progression and patient outcomes.
This project has several innovative aspects. We will be the first group applying deep generative networks to
synthesize lung CT images in ARDS, using these to predict treatment responses and injury progression. If
successful, the integration of the developed techniques in personalized clinical decision-making could
significantly impact ARDS. We hypothesize that the multi-layer neural networks will capture the hidden
characteristics of the ARDS lung after learning thousands of pairs of CT images obtained in various conditions,
such as different interventions and stages of injury. We expect this AI approach will eventually enable quantitative
imaging for prognostication and treatment selection.

Public health relevance
PROJECT NARRATIVE Acute respiratory distress syndrome (ARDS), a clinically defined hypoxemic syndrome, requires mechanical ventilation to prevent immediate death. Lung protective ventilation and prone positioning decrease mortality, but individual responses to these interventions, and clinical outcomes, are often unpredictable. Leveraging the latest developments in artificial intelligence on image synthesis, the goal of this project is to develop, train, and test deep generative models to predict ARDS progression and treatment responses from early computed tomography images.